Appalachian Career Training in Oncology (ACTION) Program

The rural Appalachian Kentucky region has the highest cancer incidence and mortality rates in the United States, and it is also one of the most economically distressed, medically deprived, and poorly educated regions of the country. These characteristics reveal a critical need for educational and scientific workforce preparedness intervention strategies targeted to this population. Through a Cancer Center Support Grant supplement in 2016, the research, clinical care, educational, and outreach strengths of the University of Kentucky’s Markey Cancer Center were leveraged to create the Appalachian Career Training In ONcology (ACTION) Program, which has been funded as a Youth Enjoy Science education intervention since 2018. In this renewal, each year the ACTION Program will immerse 20 high school and 20 undergraduate students from Appalachian Kentucky in mentored cancer research, cancer care observation experiences, cancer education and career development activities, as well as hands-on outreach activities. The goal of the program is to enhance the biomedical workforce by preparing Appalachian Kentucky high school and undergraduate students for biomedical careers, while also increasing individual’s understanding of cancer, thereby addressing the cancer and education discrepancies in Appalachian Kentucky and beyond. Impacts of the program will include: 1) supporting students’ matriculation into post-secondary, professional, and/or graduate biomedical degree programs; 2) instilling in students a lifelong commitment to research, education/outreach, and/or health care careers focused on the cancer burden and unique challenges in Appalachian Kentucky and beyond; and 3) enhancing Appalachian Kentucky’s understanding of cancer, cancer research, and clinical care, and linking these facets to the benefits of science education. The overarching goal and the program impacts will be accomplished through three Specific Aims: 1) to develop students’ cancer research knowledge and skills through cross-disciplinary faculty- and peer-mentored research training experiences; 2) to enhance students’ career preparation by providing cancer education and career development curriculum through faculty- and peer-led courses, workshops, seminars, and career coaching and mentoring; and 3) to increase the understanding of the research and clinical aspects of cancer and the importance of science education among students and teachers, parents/caregivers and families of ACTION students, and the general public through impactful outreach activities in students’ counties. New features of the program will include virtual research education experiences that complement hands-on research and education activities, a multi-institutional virtual outreach program, and a cancer curriculum outreach program for middle and high school students and teachers. With significant momentum achieved since its creation, the ACTION Program will continue having a transformational impact on Appalachian Kentucky students, their families, and their counties.

Public health relevance
The renewal of the University of Kentucky Markey Cancer Center’s Appalachian Career Training In ONcology (ACTION) Program will continue a cancer education and training opportunity for students from rural, disease-burdened, low economic, and low education-attainment Appalachian Kentucky. The program will enhance the biomedical workforce by preparing Appalachian Kentucky high school and undergraduate students for biomedical careers. ACTION will also increase individual’s understanding of cancer, thereby addressing the cancer and education discrepancies in Appalachian Kentucky and beyond.